SHARE Data Science Core

DATA SCIENCE CORE ABSTRACT
Alcohol use that is common among HIV-infected people adversely affects transmission of HIV, engagement and
retention in care, and susceptibility to coinfections. Identification of the complicating behavioral and social
determinants of alcohol use disorders and development of new effective interventions that combine behavioral
and biological strategies will greatly facilitate to treat HIV and alcohol-related morbidity and mortality and reduce
infection and transmission of HIV. A well-planned study, high quality research data, and appropriate analysis are
pivotal to addressing the relevant scientific questions and inform the development of new interventional
strategies. The Data Science Core (DSC) targets to provide a central source of expertise related to research
design, data management, and data analysis for the proposed program project to address comorbid HIV and
alcohol use. The DSC consists of a stable group of investigators with extensive experience in research design
and analysis, conducting studies, data management, and methodological development. The investigators in the
DSC will pursue the following three specific aims: (1) to provide support in translational behavioral science study
design, protocol development, data management, statistical analysis, and research dissemination for the three
research projects on management of HIV and alcohol use among Young People Living with HIV (YPLWH); (2)
to integrate disparate data sources and conduct exploratory analyses that address additional comorbidities of
HIV and alcohol in YPLWH, including other substance use, mental health, sexually transmitted infections, and
social determinants of health; and (3) to enhance the research capacity of emerging investigators through
training and mentoring in advanced and innovative research methodologies, data science support for pilot
projects, and assistance in analyzable data preparation and data analysis. The DSC is essential to ensure the
successful accomplishment of the proposed goals in this program project.